PHASE I TRIAL OF DOXORUBICIN, PACLITAXEL, AND PSC 833

PSC 833 (valspadar) is a non-immunosuppressive and non-nephrotoxic cyclosporin analogue which is a potent inhibitor of the multidrug resistance transporter, P-glycoprotein. Protocol #432 is of interest because of the activity of paclitaxel and doxorubicin in breast, ovarian and lung cancers. In this Phase I study, we are assessing the effect of PSC 833 on the pharmacokinetics and pharmacodynamics of doxorubicin and paclitaxel, with the goal of defining: a) a maximally tolerated dose (MTD) of doxorubicin with paclitaxel, and PSC, utilizing G-CSF support. Patients initially receive doxorubicin and paclitaxel and are being enrolled in cohorts of three to ten patients per cohort. Detailed phamacokinetics for doxorubicin, doxorubicinor, and paclitaxel are being performed. We anticipate that PSC 833 will significantly increase the area under the curve and the half-life of both doxorubicin and paclitaxel. This study is ongoing and should be completed during the current grant year.